Aortic Valve Calcium Prevalence, Long-term Risk Factors, and progression to Severe Aortic Stenosis Among Persons >75 Years Old

The development and progression of calcific aortic valve disease (CAVD) is a complex and multifactorial
process principally characterized by aortic valve calcification (AVC) that ultimately progresses to severe aortic
stenosis (AS). The prevalence of AVC and severe AS has the highest prevalence among persons ≥75 years
old. Currently, the only treatment for severe AS is aortic valve replacement (AVR) and as the US life
expectancy continues to increase, the number of persons needing AVR is expected to double between 2025
and 2050 to 1.4 million.
Recent provocative subgroup analyses from the Simvastatin and Ezetimibe in Aortic Stenosis (SEAS) trial
and FOURIER trial testing the PCSK9 inhibitor evolocumab showed a 35-60% lower rate of severe AS with
randomization to active treatment. These results suggest that it may be possible to prevent severe AS in
appropriately selected patients and/or using novel treatment strategies. However, there is no risk-
score/algorithm to identify older persons at high risk for severe AS. Our pioneering work in the MESA cohort of
primarily middle-aged patients has demonstrated an extremely strong association between AVC measured
using non-contrast cardiac CT and severe AS, which is even stronger than the association between coronary
artery calcium (CAC) and coronary heart disease. Additionally, we have shown that persons with a high hsCRP
and lipoprotein(a) have a significantly higher risk of developing incident AVC.
The 2011 NIH Working Group on CAVD highlighted crucial areas for research including: 1) identifying risk
factors for persons at high-risk for severe AS, 2) determining if AVC measurement may identify patients most
likely to benefit from earlier intervention, & 3) determining if there are interactions between risk factors for AS.
However, 13 years later, little is known about the potential synergy between acute phase reactants,
inflammatory markers, lipoprotein(a), and other key traditional risk factors in the risk for AVC and severe AS.
Furthermore, the distribution of AVC among older persons and its associated 5-10 year risk for severe AS
among older persons is incompletely described. The population percentiles for AVC among older persons, a
crucial reference for the clinical interpretation of AVC, is also incompletely described.
We propose to use the previously quantified AVC and meticulously phenotyped risk factor data from the ARIC
and MESA cohorts in which cardiac CT was performed among 3,242 participants age ≥75 years old to
examine the middle-age risk factors for the long-term development of AVC, create AVC population percentiles,
and adjudicate incident cases of severe AS to identify older persons at greatest risk for progression to severe
AS. These results will have a direct impact on: 1) elucidating the long-term risk factors for the development of
AVC, 2) clinical reporting of AVC results in this older age group with the highest prevalence of AVC, and 3) to
help efficiently plan clinical trial enrollment of persons most likely to benefit from new treatment therapies.
1

Public health relevance
We have previously demonstrated an extremely strong association between aortic valve calcium (AVC) and adjudicated severe aortic stenosis among middle aged persons, but little is known about this association among older persons who have the greatest risk for severe aortic stenosis. We will use data from the Atherosclerosis Risk in Communities Study (ARIC) and Multi-Ethnic Study of Atherosclerosis (MESA) cohorts to examine the potential synergy between acute phase reactants, inflammatory markers, lipoprotein(a) and other key risk factors with the long-term risk for aortic valve calcium, perform 2-physician adjudication of severe aortic stenosis events among older persons with AVC >0, and calculate population percentiles for AVC in the >75-year-old age group. The results of this study will provide a better understanding of the most important risk factors for AVC and severe AS, personalized prediction for severe aortic stenosis direct application to enrollment of planned trials, and a critically needed reference of AVC values to help determine the relative burden/severity of AVC among older persons who are at highest risk for severe AS.